Evaluating the role of cytomegalovirus and age on lung immune homeostaasis and response to respiratory infections

ABSTRACT/PROJECT SUMMARY
The immune system is important for protection against infection, cancers, allergy, and autoimmunity.
There is significant interindividual variation in the ability to mount an effective immune response that
is driven by both genetic and environmental factors. Evidence shows that underlying variation in
immune homeostasis may influence the immune response to challenge. However, the identity of
specific genes involved, and mechanism of action are largely unknown. Additionally, the interplay
between environmental stressors, genetic variation, and aging is largely understudied. The long-term
goal of this study is to understand how genetic and environmental mechanisms regulate immune
homeostasis, how this regulation changes with age, and how those factors contribute to the immune
response to infection. Our lab has previously shown that genetic diversity substantially contributes to
variation in immune responses. Further, we’ve shown that this could be mediated through changes in
the homeostatic immune environment. Here, we propose that Methyl-CpG binding domain protein 1
(MBD1) is a regulator of effector B cell differentiation at homeostasis (Aim 1). In this aim we seek to
elucidate the mechanism by which MBD1 regulates B cell differentiation and assess how allelic
variation at Mbd1 alters its functions both in vitro and in vivo. Most studies of immune homeostasis
are performed in specific-pathogen free mouse models, whose immune systems largely reflect that of
a neonatal human. To address this in the context of immune homeostasis, we will examine the
contributions of cytomegalovirus (CMV) and age to the immune environment in the lungs. Here, we
ask whether aging associated changes in the immune environment in the lungs is modified with CMV
infection, latency, and/or reactivation. Further, we will investigate whether these changes contribute to
improved immune responses to respiratory infections in aged mice (Aim 2). Data generated through
this proposal will shed new light on how immune homeostasis is modified with genetic variation, prior
immune exposure, and age, and will improve our understanding of the role that these factors play in
response to infection.

Public health relevance
PROJECT NARRATIVE The immune homeostatic state influences immune responses to infection, but is itself is a function of age, environmental stressors, and underlying genetics. Therefore, it is critical to understand the interplay between these factors and their overall impact on systemic and organ specific immunity at the steady state. This proposal studies the mechanism by which genetic variants in Methyl-CpG binding domain protein 1 regulates steady state antibody levels, and further proposes to extend the work on immune homeostasis to investigate the interaction between age and cytomegalovirus in modifying the immune architecture in the lungs and responses to respiratory infections.